Accelerating the development of novel methods to measure 24-hr physical behavior

Project Summary/Abstract
Accurate measurement of human behavior using devices could significantly advance current knowledge on the
dose-response relationships between chronic diseases and behaviors such as physical activity, sedentary
behavior, and sleep. The primary objective of this proposal is to develop valid approaches to measure 24-hour
physical behavior, as well as to demonstrate a procedure via which those approaches can be compared to
others. We aim to help the research community to converge on methods that use devices to accurately
measure physical activity type and intensity, sedentary behavior and posture, and sleep in adults. Many
promising methods have been proposed to measure behavior from activity monitors. Unfortunately, these
methods – which are now being proposed in large numbers – are typically validated on small amounts of data.
Thus, they may perform well on lab data, but fail when used in the field on large-scale epidemiological or
intervention studies. Moreover, the performance of different methods is rarely compared head-to-head,
creating uncertainty for public health researchers about which are the best to use. Quantifying the relative
performance of methods that produce similar outcome measures but use different devices or on-body device
locations is even more unusual. We will make it easy for researchers interested in physical activity
measurement to meaningfully compare performance between new methods and confidently apply those
methods to both large-scale surveillance studies and longitudinal interventions. The project has four specific
aims: (1) Collect well-annotated data of physical activity, sedentary behavior, and sleep, (2) Use the data from
Aim 1 to develop and validate approaches that yield 24-hour estimates of free-living physical activity (type,
intensity), sedentary behavior (type, posture), and sleep (wake/sleep, stages), (3) Develop and incrementally
refine a suite of tools that researchers can use to easily deploy advanced approaches to measure physical
activity, sedentary behavior, and sleep, even for large data, and (4) Use the data and new approaches (Aims 1
and 3) to host four competitions evaluating models, where all entries submitted by other researchers, will be
directly compared, ranked, and improved. The goal is to help researchers converge on “gold standard” methods
to robustly measure physical activity using common monitor configurations, as well as those devices and
configurations likely to be used soon.

Public health relevance
Project Narrative Accurate measurement of physical activity, sedentary behavior, and sleep is necessary to support new science on behavior-related dose-response for major health conditions. We propose to develop novel methods to measure 24-hour physical behavior, as well as a procedure via which those methods can be compared to others. We aim to help the research community to converge on methods that use the devices to accurately measure physical activity type and intensity, sedentary behavior and posture, and sleep in adults.